Impaired Lipophagy and Lipid Droplet Accumulation in Osteoblasts

Dr. Elizabeth Rendina-Ruedy currently maintains a faculty appointment as an Assistant Professor of Medicine
in the Vanderbilt Center for Bone Biology (VCBB), which is a component of the Division of Clinical
Pharmacology of Vanderbilt University Medical Center (VUMC). Her 13+ years of training and research has
been deeply rooted in bone biology with an emphasis in nutritional biochemistry. While the research strategy
outlined in this application will take advantage of these strengths and interests, a much more molecular,
transdisciplinary approach is proposed to determine the metabolic function of lipid droplets in osteo-progenitor
cells. As such, Dr. Rendina-Ruedy’s mentor team, Dr. Jeff Rathmell and Dr. Cliff Rosen, epitomize the
integration of the two fields, while providing impeccable support and guidance to the candidate. The applicant
and her mentors have developed an individualized plan to include structured activities that will significantly
enhance her research career, including: mentor-mentee contact; enhancing research skills, methodologies,
and expertise; involvement in courses, workshops, and training sessions; and, the dissemination of research
and knowledge. Additionally, VUMC offers an exceptional biomedical research environment, as well as
supportive staff that are committed to mentoring junior scientists. The research plan expands on preliminary
findings made by Dr. Rendina-Ruedy during her doctoral training, which demonstrated that bone-lining osteo-
progenitor cells accumulated lipid droplets in a diet-induced obese mouse model of type 2 diabetes mellitus
(T2DM). These data also corresponded to lower cancellous bone volume and a decrease in
osteoblastogenesis. These data were of particular interest given that the clinical manifestation of T2DM is
associated with an increase in fracture risk, independent of bone mineral density (BMD), along with a decrease
in bone formation. Taken together, the hypotheses being tested in the current application are that (1)
intracellular lipid droplet lipolysis via lipophagy supports bone formation by enhancing osteoblast differentiation
through the generation and utilization of energy substrates; and (2) bone formation is compromised in obesity-
related metabolic derangements such as T2DM, due to impaired lipophagy. These hypotheses will be
addressed by integrating an innovative pulse-chase, co-localization experiment (specific aim 1A), as well as
determining metabolic fuel dependency and flexibility in bone marrow stromal cells (specific aim 1B).
Additionally, we will generate a novel conditional perilipin (Plin)-2 knock out, targeted in osteo-progenitor cells
(Prx1-Cre) as a means to protect from diet-induced obesity compromise in bone by up-regulating lipolysis. In
summary, Dr. Rendina-Ruedy’s proposed project represents a highly significant research problem in the field
of bone biology that will be investigated by integrating innovative metabolic strategies. Ultimately, these data
seek to provide a greater understanding of the molecular mechanisms underlying the increased fracture risk
associated with obesity related metabolic perturbations, such as T2DM, and may impact future therapies.

Public health relevance
RE: NOT-OD-21-052 NIAMS Funded Extensions for Career Development Award (F- and K-) Recipients Whose Career Trajectories Have Been Significantly Impacted by COVID-19. My K01 award 5K01AR072123 is in the last year of funding. My research activities along with the establishment of my research program were severely interrupted by the COVID-19 pandemic. This included hindered research, training, and career development over and above lost research and productivity that most individuals experienced during this period. In addition to the sections that follow, its critical to highlight that I only started my lab in July 2019. Therefore, that left me with 8 months prior to the pandemic to ‘start’ my lab including ordering all equipment and reagents, transferring/ shipping mice, as well as hiring and training personnel. This unfortunate timing has uniquely impacted my progress and establishment of a successful research program. Research Activities and Training: • From March 16th to May 12th, 2020, laboratories were down to minimal activity and core facilities were closed at Vanderbilt University Medical Center (VUMC). During this time data generation was stopped. • VUMC designed a 4 staged plan to ensure the safety during the COVID-19 pandemic with strict physical distancing rules. During Phase 1 after reopening (May 13th to June 7th 2020), laboratories were asked to perform only basic operations and to reduce the mice colonies to 20%. My laboratory performed only experiments that were related to maintaining mouse colonies in the animal facility. The laboratory has a mouse colony with a total of ten mouse strains, five of which are being used in the experiments related to the K01. • Phase 2 started June 8th 2020. During this phase, we were allowed to re-start re-establishing the mouse colony which takes significant time. During Phase 2, core facilities started working with minimal occupancy to keep social distancing and animal facilities started to allow experiment to be perform following strict social distancing rules. • My laboratory is in the Medical Research Building IV (Light Hall). Due to space restrictions during Phase 1 only one person was allowed at any time in the space. Starting at Phase 2, two people were allowed to work in my laboratory granted social distancing rules. All the changes made to stop the spreading of the virus causing COVID-19 halted normal progression of my research program. Specifically, the experiments planned in this K01 research plan were affected. Personnel: • Before the pandemic, the research assistant (RA) that was with me in Maine joined the lab in September 2019. He was a huge asset to the lab but left in May 2020 as he was accepted into medical school. Again, this was only 8 months prior to my arrival and full responsibilities to start my lab. This caused a significant delay in the research progress in my laboratory. I had to perform experiments and maintain the mouse colony. • I was able to hire a part-time research assistant in July 2020, but due to social distancing and space limitations it was incredibly difficult to train this individual. This RA subsequently left the lab May 2022. • Despite my best efforts, hiring personnel to establish my lab has been a lingering consequence of the pandemic. I’ve had multiple job postings open for over a year. Only withing the past month have I received qualified applications. Personal Responsibilities: • My daughter was in preschool at the start of the pandemic (March 2020). Due to the severity and uncertainty, we paused stopped her attendance and allowed her to stay at home. My husband and I rotated days, but this was an incredible strain. We re-enrolled her July 2020 for pre-kindergarten. Even during this time, periodic outbreaks would occur, and the school would close. This left us responsible for her childcare. This had a significant impact on my productivity. • During this time, my husband’s job was “paused” at the end of March in 2020, with no indication of a re- opening date. This put a large strain on my family. With this uncertainty, he took another position in June 2020. He is still currently in this position, but this position has significantly changed our schedules which has impacted my scientific productivity. • I also experienced the birth of a child in December 2021. As described above my laboratory research interruptions account for more than 6 months. Despite all these challenges, and as Phase 2 started, I incremented the research activities to produce preliminary data for additional grants. While I was fortunate to secure an R01 through the NIA, most of this grant was written prior to the pandemic. If awarded, I will use the extension to finish the K01 experiments not performed due to the pandemic, continue generating preliminary data for new grants which are crucial to maintain my position as a tenure track assistant professor at Vanderbilt University Medical Center.